Administrative Core

PROJECT SUMMARY - ADMINISTRATIVE CORE
The Administrative Core provides leadership and governance for the proposed UCSD Learning Health
Systems Center and ensures that the program activities remain within the Center's scientific area of focus. The
Principal Investigator, Dr. Ming Tai-Seale, and Co-Principal Investigator, Dr. Michael Hogarth, with the
assistance of the administrative core staff, an Executive Committee and Advisory Committee will ensure that
the core services are of the highest quality and that the core resources are used efficiently and equitably by
Learning Health System Scientists at UCSD and community partners. The Administrative Core will manage
and coordinate interactions among the PI, Co-PI, Advisory Committee, Executive Committee, the core
directors, LHS Scientists, mentors, other researchers at UC San Diego, as well as community partners (El
Centro Regional Medical Center, Family Health Centers of San Diego), three patient stakeholders, four health
system stakeholders, AHRQ and PCORI program officers. UC San Diego has a track record of excellence in
training clinical and research scientists. We have longstanding and well-established partnerships with multiple
federally qualified health centers and other healthcare delivery systems in the area and across the U.S. The
Administrative Core will lead outreach efforts and use multiple communication methods, including in-person
conversations, virtual meeting, and a website about the Center with FAQs, to ensure that all members of the
UCSD community, community partners, and professionals with an affinity to LHS science are aware of the
opportunity to engage with the proposed UCSD LHS Center. Building on principles of justice, equity, diversity,
and inclusion, and the Asset-Based Community Development framework, every effort will be made to recruit
and retain qualified LHS Scientists. The proposed UCSD LHS Center focuses on the application and mastery
of the AHRQ core LHS scientist competencies to support the professional development of scientists to conduct
research that accelerates progress towards an integrated learning health system. The UCSD LHS Center will
build new models of LHS infrastructure that support and enhance existing institutional training and research
infrastructure organized around shared resources and research infrastructure. The Administrative Core will
support matriculated LHS Scientists by facilitating mentoring and training relationships with faculty and
community partners that align with their research interests. Career development opportunities will be
coordinated. By bringing together faculty mentors and methodologists, the proposed Center will be able to use
and pool knowledge of mentors to develop the didactic curriculum and learn from one another as they share
their experiences in helping LHS Scientists to navigate their way through successful LHS projects. This
approach will produce a cadre of LHS Scientists, LHS mentors, and rapid learning LHS projects that can
accelerate advances in knowledge, health system performance, and patient outcomes.